Impact of changing restaurant advertising on weight gain and disparities

Summary. Obesity is associated with 13 cancers and up to 11% of cancer in the United States is associated
with excess body mass index (BMI). Evidence suggests that the food environment is associated with obesity
risk, which affects one third of adults. Restaurants are an important component of the food environment. Onethird of Americans will eat at a fast food restaurant on a typical day. Restaurant sales have steadily increased
over the past 5 decades; in 2015 restaurants spent $6.3 trillion in advertising (more than 100 times the NIH
budget). Advertisements for unhealthy items are often targeted towards those at higher risk for obesity, and
unhealthy food retail outlets, like fast food restaurants, are more densely located in low-income and minority
communities. Therefore, the restaurant environment may more negatively impact low-income and racial
minority populations. To date, research on the relationship between restaurant advertising and obesity risk has
largely focused on children. Available studies are limited by cross-sectional data (limiting identification of
causal relationships). To address these knowledge gaps, we will combine multiple data sources to create a
unique, objective measure of local per capita restaurant advertising (adapting an approach we previously
developed). This will be derived from local-level quarterly restaurant advertising spending from Kantar Media
for the 100 top revenue generating restaurants in the U.S. and the annual physical addresses for all locations
from each restaurant chain from AggData. We will test associations of restaurant advertising per capita with
population weight gain using objectively measured BMI data for 2.3 million people (in 217 counties across 40
states and the District of Columbia, including 9 of the 10 most populous U.S. counties) from athenahealth. We
will test whether this relationship is mediated by advertising exposure using data from Neilson Ad Intel. The
overall objective is to leverage national data and provide a much-needed understanding of how exposure to
changes in local restaurant advertising impacts adult weight gain and disparities. We propose two specific
aims: 1) examine changes in chain restaurant advertising expenditures from 2012 to 2016 and test whether
those changes vary by income and race/ethnicity and 2) estimate the associations between chain restaurant
advertising and weight gain among U.S. adults, by race and SES and whether this relationship is mediated by
the level of exposure to advertising. We will use a set of econometric techniques to assess whether these
relationships are causal. We hypothesize that increases in restaurant advertising per capita were larger in
areas with higher concentrations of racial/ethnic minority and low-income populations and that greater
exposure to restaurant advertising will be associated with higher weight gain, particularly for low-income and
racial/ethnic minority populations and those with higher advertising exposure. This research will make a highly
significant contribution to our understanding of how restaurant advertising impacts weight gain and disparities
among adults, with important implications for subsequent cancer outcomes and health equity.